Supplement for Equipment Purchase - Hyperspectral Near Infrared Confocal Microscope

PROJECT SUMMARY/ABSTRACT
Nitric oxide (NO) is a key signaling molecule in biological systems, but it is poorly understood
due to a lack of temporal and spatial sensors that measure NO. A direct, fast and accurate
sensor for measuring NO would be of immense value to ongoing and future research. Single
walled carbon nanotubes (SWNT) have excellent potential for use as NO sensors both in vitro
and in vivo, but they are not widely used by the research community because they are not
readily available in an easy-to-use platform. The Iverson Lab aims to 1) develop new SWNT
sensor platforms and modify the current systems to improve sensor specificity and handling,
and 2) determine nitric oxide concentration and dynamics with a highly sensitive and accurate
sensor. Through the acquisition of a near infrared, hyperspectral confocal microscope, we will
be able to more quickly and more accurately accomplish the goals of the R35 parent grant and
increase the impact of the funds already supplied by the NIH.

Public health relevance
PROJECT NARRATIVE Nitric oxide is a small molecule that is required for cell signaling. Unfortunately, researchers know very little about the concentration and movement of nitric oxide because of a lack of easy- to-use, real-time sensors. The Iverson Laboratory will use a near infrared, hyperspectral confocal microscope to image single walled carbon nanotube sensors for nitric oxide to expand current understanding of the biological processes in which nitric oxide is involved.